Outreach Core

Outreach Core
SUMMARY
The CSBC Research Center for Tumor-Immune Systems Biology at MSKCC outreach core program will
encompass undergraduate and graduate education and cross-training in systems biology and immunology,
computational biology, and bioinformatics and focus on scientific outreach within the local, national and
international scientific communities. The recent clinical successes of cancer immunotherapy, in particular
immune checkpoint blockade, have captured the attention of cancer biologists—and the imagination of the
public—by demonstrating the critical role of the immune system in cancer progression and response to therapy.
The broad aim of the Outreach Core is to disseminate the knowledge of tumor-immune cell interactions in distinct
microenvironments from a systems biology perspective, role of the tumor-immune cell interactions in cancer
progression. We propose a suite of outreach and education activities in cancer systems immunology to bring
new developments in this field to the public, STEM students and the broader scientific community and to
encourage the next generation of cancer systems biologists to obtain training in immunology and pursue new
immunological strategies for cancer therapy.